TO PROVIDE FUNDS FOR THE EXERCISE OF OPTION PERIOD 2, FOR THE PERIOD OF PERFORMANCE FROM MAY 1, 2016 THROUGH APRIL 30, 2017.

The NHLBI Office of Science Policy, Engagement, Education and Communications (OSPEEC) provides comprehensive, integrated, and technology-driven communications support for all matters relating to outreach-oriented programs and activities directed toward the Institute's vision and mission; serves as the Institute’s focal point for establishing and implementing information and education programs; develops short- and long-term communication policies and strategies in support of the mission and priorities of the NHLBI; addresses emerging and evolving communications, science planning and policy issues in consultation with internal and external stakeholders; provides a comprehensive and integrated information dissemination and education capability to ensure rapid, accurate, and consistent communications to the constituencies served by NHLBI; sets and provides oversight of policies and processes governing public-facing information channels including, but not limited to, NHLBI’s digital platforms; promotes the evolving NHLBI identity, and coordinates and integrates the activities of the Engagement and Media Relations Branch; Health Education and Digital Information Dissemination Branch; and Science Policy, Outreach, and Reporting Branch.